Development and application of a new simulation model for COVID-19

This project leverages the Cost-effectiveness of Preventing AIDS Complications (CEPAC) team to develop a novel computer microsimulation model of COVID-19 disease to assess the impact of testing and treatment interventions in diverse populations in the United States, and to conduct both modeling and registry work to inform that model.

Public health relevance
This powerful dynamic microsimulation model of COVID-19 can address the impact and outcomes of different management strategies for COVID-19 in various populations in the US.